PHD2 mediated loss of hypoxia signaling limits skeletal muscle regeneration and exercise response in aging

PROJECT SUMMARY/ABSTRACT
I am interested in developing novel treatment strategies for maintaining muscle mass and function in the
elderly population. My lab utilizes murine models of aging to investigate mechanisms on how aging-associated
loss of hypoxia signaling in skeletal muscle affects two key factors in maintenance of muscle mass and
function: (1) skeletal muscle regeneration and (2) adaptation to aerobic exercise. Prolyl hydroxylase domain
enzyme (PHD)2 increases profoundly in skeletal muscle with aging and is a key regulator of the hypoxia
signaling pathway. This increase in skeletal muscle PHD2 leads to loss of hypoxia inducible factor (HIF)-1, a
central transcription factor responsible for downstream hypoxia pathway signaling. Using a murine model of
aging and genetically modified mice, we have demonstrated that a muscle specific increase in PHD2
recapitulates diminished skeletal muscle regeneration and loss of aerobic exercise adaptation as seen in
aging. Building on these intriguing pilot data, the central goals of this project are to (1) mechanistically define
the role of PHD2 and its impact on muscle regeneration in aging, (2) determine whether PHD2 inhibition
preserves skeletal muscle myogenic potential with aging, and (3) evaluate if increased skeletal muscle PHD2
in aging limits muscle adaptation in response to aerobic exercise. Importantly, transcriptome analysis in
humans also demonstrates decreased hypoxia signaling in old skeletal muscle, suggesting translational
potential for hypoxia signaling targets. As FDA approved PHD2 inhibitors are available, an improved
mechanistic understanding of hypoxia signaling as it relates to skeletal muscle regeneration and exercise
response may offer therapeutic opportunities for elderly patients suffering from loss of muscle function with
aging.

Public health relevance
PROJECT NARRATIVE Aging results in a severe decline of skeletal muscle regenerative potential and a diminished response to aerobic exercise, which manifests clinically as impaired muscle function, increased risk of adverse events, and loss of independence. The proposed study will advance our mechanistic understanding of how dysregulation of the hypoxia signaling pathway in aging impacts muscle regeneration and aerobic exercise adaptation. Importantly, it will further evaluate whether restoration of hypoxia signaling improves muscle function in a murine model of aging.